Development of a systems pharmacology agent for treatment of bronchopulmonary dysplasia

ReNeuroGen LLC is seeking a $50,000 TABA NHLBI SBIR administrative supplement to support regulatory
planning and engagement with the FDA for our therapeutic development program targeting Bronchopulmonary
Dysplasia (BPD). This request is submitted under PA-20-272 to supplement our existing NHLBI-funded Direct-
to-Phase II SBIR grant R44HL166018 entitled “Development of a systems pharmacology agent for treatment of
bronchopulmonary dysplasia.” Our novel drug candidate, N-acetyl-lysyltyrosylcysteine amide (KYC), is an end-
capped tripeptide/small molecule that is a first-in-class systems pharmacology drug with demonstrated efficacy
in both rat and rabbit models of BPD. ReNeuroGen operates as a virtual pharmaceutical company (vPharma), a
strategic model outlined in detail in our original Phase II SBIR Commercialization Plan. This model emphasizes
lean infrastructure and the targeted use of specialized external expertise. Accordingly, to de-risk the KYC
program and define a clear regulatory path to IND filing, we are seeking support to engage RareMoon
Consulting—a regulatory advisory firm with a strong track record in pediatric and orphan drug development,
including FDA pre-IND meeting preparation and IND submission strategy.

Public health relevance
ReNeuroGen LLC is seeking an administrative supplement to support regulatory planning and engagement with the FDA for our therapeutic development program targeting Bronchopulmonary Dysplasia (BPD) for the existing NHLBI-funded Direct-to-Phase II SBIR grant R44HL166018 entitled “Development of a systems pharmacology agent for treatment of bronchopulmonary dysplasia.” To derisk our program and define a clear regulatory path to IND filing, we are seeking support to engage RareMoon Consulting—a regulatory advisory firm with a strong track record in pediatric and orphan drug development, including FDA pre-IND meeting preparation and IND submission strategy.